Hypoxia and mitochondria in spine development and congenital scoliosis

ABSTRACT
Vertebrae originate from somites during embryonic development. Somites are segmented from the
presomitic mesoderm (PSM) and the process is known as somitogenesis. Somitogenesis is controlled by key
Notch signals in the PSM that oscillate with a periodicity matching that of somite formation. Hypoxia occurs
naturally in developing embryos before the circulatory system is established. However, exacerbation of hypoxia
as it may take place during gestation disrupts the oscillatory Notch signals in the PSM and leads to abnormal
somitogenesis and altered spine development. Spondylocostal Dysostosis (SCDO) is characterized by severe
vertebral malformations and is caused by homozygous loss-of-function mutations of components of the Notch
signaling pathway. Mice carrying similar homozygous mutations phenocopy the human disease. Heterozygous
Notch LOF mutations cause the more modest, although more frequent, human defect of congenital scoliosis
(CS), which is also phenocopied in heterozygous mouse mutants. These mice phenotypes are worsened by
gestational hypoxia. The mediators of the hypoxic response are the transcription factors Hypoxia-Inducible
Factor-1alpha (HIF1) and HIF2. The role of HIF1 and HIF2 in somitogenesis has not been addressed. To fill
this gap of knowledge, we conditionally inactivated HIF1 in the PSM using TCre transgenic mice (HIF1
mutants). Loss of HIF1 in the PSM causes abnormal somitogenesis and spine malformations reminiscent of
SCDO/CS and gestational hypoxia. Conversely, preliminary data showed that HIF2 is not necessary for spine
development, but the concomitant loss of HIF1 and HIF2 ameliorates the spine abnormalities observed in HIF1
mutants. Hypoxia increases stability and transcriptional activity of the HIFs; therefore, we were intrigued by the
observation that gestational hypoxia and loss of HIF1 in the PSM alter somitogenesis in a similar manner.
Notably, both loss of HIF1 and gestational hypoxia led to an increase in intracellular hypoxia in the PSM.
Furthermore, preliminary findings revealed that the impairing of mitochondrial respiration, which was used as a
tool to reduce intracellular hypoxia, partially corrected the spine defects observed in HIF1 mutants. Considering
our preliminary data, ourworking hypothesis is thatboth loss of HIF1 in the PSM and gestational hypoxia
increase intracellular hypoxia, which in turn dysregulates the Notch signaling pathway and alters
somitogenesis. We also hypothesize that loss of HIF1 in the PSM stabilizes HIF2 by increasing intracellular
hypoxia, and the augmented HIF2 transcriptional activity mediates some of the effects due to loss of HIF1. Our
hypotheses will be tested in two Aims. Accomplishment of the proposed experiments will establish, for the first
time to our knowledge, the role of HIFs and mitochondria respiration in somitogenesis. It will position HIF1
upstream of the Notch signaling pathway in PSM. It will shed new light into our current understanding of the in
vivo cross-talks between HIF1 and HIF2. Lastly, it will provide novel insights into the pathogenetic mechanisms
leading to congenital scoliosis because of gestational hypoxia.

Public health relevance
NARRATIVE If successful, this proposal will significantly advance our understanding of how hypoxia, hypoxia-driven pathways, and bioenergetic metabolism control somitogenesis. The successful accomplishment of the experimental plan described in this proposal may identify the transcription factors HIF-1alpha and HIF2-alpha as novel regulators of somitogenesis. This knowledge could provide novels insights into the pathogenetic mechanisms underlying both Spondylocostal Dysostosis and Congenital Scoliosis due to gestational hypoxia.